Signal Processing And Instrumentation Section

The research and development activities of the Signal Processing and Instrumentation Section (SPIS) are collaborative efforts with NIH Institute scientists that require the development of biomedical laboratory and clinical research systems, instrumentation, and methodologies. The majority of these collaborations require novel approaches and designs for which there are minimal established criteria or technical knowledge. SPIS staff have in-depth technical experience in all phases of engineering research and development. With their collaborators, SPIS staff review the clinical and biomedical sciences to formulate project specifications. SPIS staff evaluate the theoretical and practical constraints, consider commercially available technologies, and finally propose various solutions. SPIS responsibilities often continue with the hands-on design, implementation, testing, installation, training, documentation, and production of a custom research system or methodology. Current collaborative projects, as well as associated research studies include: 1. 3D Printing Applications in Analytical Ultracentrifugation Technologies 2. Agarose Molding Stamp for High-Throughput Zebrafish Imaging 3. Artificial Tick Feeding Chamber 4. Assessing the Value of Baseline 18F-NaF PET-CT Global Parameters to Predict Calcium Content 5. Assessment of Blood Vessel Density in Kaposi's Sarcoma Lesions Using Multi-modality Imaging Techniques 6. Augmented Reality Application for Interactive Enhancements for Scientific Data Visualization and Manipulation 7. Automation of Tissue Staining Pipeline for Multiplex Antibody Assays and Histopathology 8. Characterizing Spontaneous Movements During Early Development of Mice 9. Chemical Analysis of Collected Breath Droplet Particles to Explore Hydrogen Peroxide as a Disinfectant 10. COVID-19 Autopsy Containment Box 11. CT Lung Visualization Using VR/AR Technology 12. Custom-made Macaque Brain Molds to Correlate MR Imaging to Whole-brain Histology 13. Development and Characterization of a Handheld Diffuse Optical Spectroscopy System 14. Development of Advanced Analytical Ultracentrifugation Fluorescence Detectors and Acquisition Systems to Study the Dynamics of Protein Assemblies 15. Development of Ear Savers to Reduce Ear Strain from Face Masks for COVID-19 Pandemic 16. Development of Multi-Well Incubation Chamber for Rodent Brain Tissue Studies 17. Diffusion Exchange Functional MRI 18. Elutrap Spacer for In Vitro Biochemical Assays 19. Ex Vivo Model Using Human Peritoneum for Primary and Metastatic Cancer or Human Mesothelial Surfaces 20. Fetal Brain DWI Imaging, Reconstructions, and 3D Rendering/Analysis 21. Functional Near Infrared Spectroscopy System (fNIRS) for Brain Imaging 22. Glymphatics MRI Phantom Development 23. Grid Holders for Electron Microscopy 24. Hands-free 3D-printed Door Opener to Minimize Spread of Coronavirus 25. Illumination Control System for Mouse Visual Cycle Studies Relating to Retinal Dystrophies 26. Imaging Flow in Capillary Structures with Low Flowrates and Veinous Exchange 27. Imaging/Interrogation of Metastatic Colonization in Perfused Resected Liver 28. Improved Restricted Exchange Environmental Chamber (REEC) 29. Improved Transurethral Resection (TUR) Device 30. Instrumentation to Measure Response Properties of Somatosensory Neurons 31. Intra-vital Microscopy Using Non-linear Optical Techniques 32. Investigation of Pituitary Tumors and Related Hypothalamic Disorders Using Multi-modality Imaging Techniques 33. Investigation of Short- and Long-term Effects of COVID-19 on Cognitive Functions 34. Laser Welder for Sterile Filling of Tubing for Hyperpolarized MRI Experiments 35. Liver Transducer Holder to Disperse Vibrations 36. Methods for Soft Tissue Prostate Procurement Using Patient-specific MRI-based Guiding Fixture 37. Micro Trimmer for Electron Microscopy and X-Ray Tomography Sample Preparation 38. Microfabricated Polymeric Vessel Mimetics for Cancer Cell Culture 39. Microfluidic Device Setup to Combine the Controlled Delivery of Oxygen with Real-Time Measurement of Intracellular Oxygen Concentration and Metabolism In Vitro 40. Microfluidic PNA-based HIV RNA Detection System 41. Microfluidic/Organ-on-a-chip Mold to Model Fibrotic Response to Medical Device Implants 42. Microfluidics, Microfabrication, and Microanalysis Technologies for Biomedical Research 43. Mirror Neuron Network Dysfunction as an Early Biomarker of Neurodevelopmental Disorder 44. Mold to Cast Microarrays for Spheroid Embedding 45. Mouse Catheterization Holder to Instill Bladder Tumor Cells into the Bladder 46. Mouse Home-Cage Monitoring Device for Learning and Memory 47. Mouse Pup Holder for Anesthesia Delivery and Surgery 48. Mouse Whisker Tracking and Texture Preference for Brain Neural Circuit Studies (Behavior Box) 49. MRI Elastography for Anisotropic Materials 50. Multimodal Nonlinear Microscopy with Spectral-focusing CARS and Stimulated Emission 51. Multi-Well Tissue Processing Trays for Neuronal Circuit Studies 52. Next Generation Electroconvulsive Therapy (ECT) System 53. NIH Equipment Monitoring System 54. OCT - Adaptive Optics Retinal Imaging with Eye Tracking 55. Pellet Culture (3D) Bioreactor for In Vitro Cultivation of Bone Growth Plate Cartilage Tissue 56. Phantom Design to Simulate Biomechanical Coupling of Skull and Brain for Magnetic Resonance Elastography Experiments 57. Portable Low-Field Magnetic Resonance Imager 58. PRiME: Physiological Recording in MRI Environment for Cardiovascular Intervention 59. Prostate Methods Correlating Multiparametric MRI with Histopathology of Prostatectomy Specimens Using Patient-specific MRI-based Prostate Mold 60. Quality Management System and Current Good Manufacturing Practices 61. Quantitative Characterization of Normal and Disease Cervix Tissue Development 62. Quantitative Evaluation of Dynamic Activity of HeLa Cells in Different Viability States Using Dynamic Full-field Optical Coherence Microscopy 63. Rapidscan Continuous Wave Electron Paramagnetic Resonance Imaging of Nitroxide Reduction for Redox Status of Tissue 64. Real-time Oximetry of Anterior Placenta Using Near Infrared Spectroscopy and Ultrasound Integration 65. Recording Spinal Cord Neuron Activity During Mouse Behavior 66. Rodent Arena Tracker (RAT) 67. Self-Collection Homebased Biosensor for Monitoring and Tracking Suspected COVID-19 Patients 68. SLO - Adaptive Optics Retinal Imaging with Eye Tracking 69. Spinal Cord Cellular Basis of a Simple Movement 70. System for Continuous Observation of Rodents in Home-cage Environment (SCORHE): Phenotyping and Behavioral Assays 71. System to Measure Distortion Product Otoacoustic Emissions 72. System to Measure Rodent Vestibular Sensory Evoked Potentials 73. Technologies and Mouse-based Instrumentation for Spinal Learning Studies 74. Tenodesis Type Action Hand Prosthesis for Pediatric Rehabilitation 75. Therapeutic Application of Induced Electromagnetic Fields (EMFs) to Reduce Cell Growth and Migration in Glioblastoma Multiforme (GBM) 76. Time Domain Electron Paramagnetic Resonance Imaging of Oxygen Status Corresponding to Cancer Treatments 77. Tissue Culture Matrix Casting for Spheroid Growth and Histology 78. Tissue Freezing Cassette 79. Tissue Vacutainer Device 80. Using Light-sheet Microscopy to Understand Evoked Motor Sequence Generation in Drosophila 81. Video Analysis System for Behavior and Activity Assessment of Fruit-Flies in High-Throughput Studies 82. Video Monitoring System for Automated Detection of Pain Related Mice Behaviors 83. Video-Based Breathing Rate Detection for COVID-19 Hamsters 84. Walk-away Radiochemistry Laboratory Automation 85. X-clometer - New Radiographic Marker 86. Zebrafish Intubation Chamber for Longitudinal Imaging